USE OF MIDODRINE IN ORTHOSTATIC HYPOTENSION

The purpose of this study is to determine the blood pressure raising effects of midodrine in patients with chronic symptomatic orthostatic hypotension. The study design is a double-blind crossover trial with a placebo lead in.